Neutralization of Primate Immunodeficiency Viruses

We will repurpose existing assays, techniques and expertise that are central to our project team’s virology, structural biology, vaccine development and protein production skill-sets for HIV research, to now also work on SARS-CoV-2 during the COVID-19 pandemic emergency. These interactive research efforts will draw on our established methodologies and should represent a productive use of our existing NIH grant resources. We note that there continue to be institutional restrictions at all three performance sites on the effort that can be applied to our original goals relating to HIV-1 vaccine research and development. Those goals will be unchanged, but will be pursued at a reduced effort during the period when we also work on the new SARS-CoV-2 projects for which we have fewer institutional restrictions due to the COVID-19 pandemic.

Public health relevance
The COVID-19 pandemic is a national emergency and an international public health crisis. By repurposing our existing experience of HIV-1 virology, structural biology, vaccine development and protein production, we intend to contribute to the scientific community’s wider efforts to devise better ways to treat and vaccinate against SARS-CoV-2 infection of humans.